The Physical Microenvironment in Cancer Biology and Therapy

DESCRIPTION (provided by applicant): No Abstract was provided.

Public health relevance
Relevance We propose that Cancer is a dynamic complex multiscale system that can only truly be understood via the integration of theory and experiments. The goal of the proposal is to use such an integrated approach to better understand, predict and treat cancer